Analysis Core (Anc)

REVISED ABSTRACT - AnC:
The goal of the Data and Analysis Core (AnC) of the proposed Alzheimer's-related RCMAR (AD-RCMAR), Mass-ENVISION, is to support RCMAR Scientists through consultation, guidance, and hands- on support for the implementation of best data practices. In conducting the proposed Alzheimer disease and related dementias (ADRD) research projects, RCMAR Scientists will need to rely on standard data collection and analysis tools as well as develop new tools and innovate in the leveraging of novel, often technology-driven, tools. The AnC will provide guidance on implementing best practices, and navigating the substantial expertise and resources available to RCMAR Scientists through Mass-ENVISION affiliations with Massachusetts General Hospital, Brigham and Women’s Hospital, Harvard Medical School, Boston University (BU) and BU School of Medicine, Cambridge Health Alliance, the Massachusetts Alzheimer’s Disease Research Center (MADRC), BU-ADRC, Boston Claude O. Pepper Older Americans Independence Center (OAIC), Hebrew SeniorLife, and more. The AnC will be led by Drs. Bettina Hoeppner and Benjamin Cook, and will be supported by access to experienced statisticians, qualitative data experts and system engineers. Our team builds on four key strengths: (1) deep mentoring experience across research settings and topics, where our AnC members have served as mentors on numerous NIH-funded career development awards (e.g., F32s, K01s, K23s, K12s); (2) a focus on populations with health disparities , for whom our AnC Co-Leads run behavioral and social science research projects focusing on (3) demonstrated investment in pooling science-advancing resources and making them broadly available (e.g., PI of NIDA-funded R24 on advancing the science on recovery community centers); and (4) a shared dedication to mentorship of promising scientists from all backgrounds The specific aims of the AnC are to: 1) Provide (statistical, data analysis) mentoring to RCMAR Scientists; 2) Support unique and emerging measurement needs for RCMAR Scientists; 3) Provide guidance on mHealth data to RCMAR Scientists; and 4) Curate existing and emerging data sources across Mass-ENVISION and AD-RCMARs. In summary, the proposed Mass-ENVISION Data and Analysis Core will support RCMAR Scientists through consultation, guidance, and hands-on support at key points during the progress of their projects. The AnC will guide RCMAR Scientists in best data practices that will enable the rapid translation of their research findings into publications, promote their long- term research career success, and facilitate the harmonization of data sources across RCMAR studies.